Human mitochondrial ACP interactions

7. Project Summary. Mitochondrial damage, and mitochondrial fatty acid synthase (mtFAS) disorders in
particular, have been associated with aging and neurodegenerative disease. Historically these disorders were
attributed to a decrease in lipoic acid production, however, this conclusion has recently come into question with
the growing evidence that the mitochondrial acyl carrier protein (mtACP), the substrate-shuttling protein of
mtFAS, plays a much greater role within mitochondrial metabolic pathways. A hierarchy of mtACP regulation,
from mitochondrial protein translation to respiratory complex assembly, has been recently revealed, however
the molecular basis of such control remains unclear. This program aims to apply new chemical, structural, and
biophysical tools to understand how acyl-mtACP interacts within the mitochondrial metabolism. Given the
central role of the mitochondria in cellular metabolism, this program will fundamentally impact our
understanding of aging and health maintenance and provide potential new avenues to treatment of
mitochondrial diseases.

Public health relevance
8. Project Narrative. Mitochondrial damage, and mitochondrial fatty acid synthase disorders in particular, have been associated with aging and neurodegenerative disease. Historically many studies have attributed these disease phenotypes to a decrease in lipoic acid production, however, this conclusion has recently come into question. This program applies new chemical biology tools to understand how the mitochondrial acyl carrier protein interacts within the greater mitochondrial metabolism to better understand aging and health maintenance.